Program in Blood Coagulation and Vascular Biology

Abstract
The goal of this program is to train MD and PhD postdoctoral fellows in biomedical research as it
applies to Blood Coagulation and Vascular Biology. We offer a multi-disciplinary program that
consists of didactic instruction, seminars and supervised research. Important elements of the
curriculum are supervision by faculty advisors, formal course work, interactions between trainee
and the faculty, and interactions between the trainee and peers. The Program is designed around
three distinct tracks. MD trainees choose between two tracks. The Physician-Scientist Track
consists of a minimum of two years of supervised bench research and didactic instruction after
completion of the major portion of hospital-funded clinical subspecialty training. The Clinical
Investigator Track prepares MD participants for a career in clinical investigation in the areas of
blood coagulation and vascular biology. PhD trainees participate in the Basic Science Track. The
design of the program takes into account (a) the need for physicians to acquire knowledge of
advances in molecular and cell biology, genetics, bioengineering, animal models, and systems
biology; (b) the need for an extended training experience to allow fellows to develop sophistication
in modern biomedical research; (c) the need for PhD scientists to understand the biochemistry of
the coagulation system and the pathobiology of the vascular system. Dr. Robert Flaumenhaft is
the Program Director and Drs. Sol Schulman, Kenneth Bauer, and Elisabeth Battinelli are
the Track Leaders. Faculty of the program, members of the Department of Medicine at Beth
Israel Deaconess Medical Center and Harvard Medical School, share a scientific interest in
blood coagulation and vascular biology. MD trainees are selected from >100 applicants each
year. Only those applicants with an explicit commitment to a career in academic medicine are
selected. This grant, funded for the past 23 years, is a continuation of T32 HL07437, which had
been active at Tufts Medical Center for 20 years. This training program has proven
exceptionally successful. Over past 5 years, 82% of our recent alumni have remained in
academia and 18% are employed in industry. Of those in academia, half have already attained
federal funding for their independent research projects. This Program has, in the past 4
decades, produced leaders in the fields of blood coagulation and vascular biology and has had
important impact in sustaining basic research in the field of hemostasis and thrombosis.

Public health relevance
Project Narrative Research in hemostasis, thrombosis, and vascular biology addresses fundamental mechanisms underlying bleeding, thrombotic disorders, and diseases of the blood vessels. Taken together, these pathologies account for more than half of all morbidity and mortality among U.S. citizens. This Program in Blood Coagulation and Vascular Biology will train the next generation of scientists to study problems related to hemostasis, thrombosis, and vascular biology.